Career Enhancement Core

The Center for the Assessment of Tobacco Regulations Career Enhancement Core (CEC) will serve as the
hub within CAsToR to promote and support the career development of new and early-stage investigators. The
overall goal of the CEC is to support the advancement of junior researchers in becoming independent Tobacco
Regulatory Science (TRS) investigators who use, or collaborate with others who use, simulation and
computational modeling approaches in TRS. The CEC will provide junior investigators with mentored research
experiences, educational activities, mentorship, professional networking opportunities, and scientific
communications training in TRS, with an emphasis on simulation and computational modeling research.